A role for TREM2/Abeta interactions in microglia-regulated AD pathogenesis

PROJECT SUMMARY Alzheimer’s disease (“AD”) is a progressive late-onset neurodegenerative disorder which manifests in memory loss and cognitive decline. AD involves the pathological accumulation of Aβ-enriched plaques and neurofibrillary tangles comprising phosphorylated tau in the human brain. Although neurotoxic Aβ oligomers are thought to contribute to neurological decline, mechanisms underlying Aβ clearance and Aβ-induced neuroinflammation invariably linked to AD onset remain elusive. In addition to familial AD mutations in APP and PS1, genome-wide association studies (GWAS) in AD have uncovered genes such as CD33, CR1, MS4A, ABCA7, EPHA1 and TREM2 enriched in microglia and myeloid cell types, suggesting that AD pathogenesis may be modulated by microglial activation and function. The microglial transmembrane receptor, TREM2 (Triggering Receptor Expressed on Myeloid cells 2) may be of particular interest as R47H ectodomain mutations have potent effects in increasing odds for triggering AD onset. Given that AD is invariably associated with a neuroinflammatory etiology, it seems likely that TREM2-related microglial function may modulate neurodegenerative AD onset. Although ligands for TREM2 such as ApoE have been previously identified, a definitive mechanism for TREM2 in AD has not been established. Here, we provide evidence that TREM2 directly binds Aβ oligomers with nanomolar affinity and R47H mutations attenuate TREM2/Aβ interaction. TREM2 deletion impairs Aβ turnover in primary microglia, and abrogates Aβ clearance in vivo. Aβ also triggers changes in microglial membrane potential which is impaired with TREM2 deletion. Moreover, TREM2 deletion attenuates Aβ-induced microglial morphogenic changes associated with activation, and inhibits Aβ-mediated induction of proinflammatory cytokine expression. Together, these results indicate that TREM2 may have opposing neuroprotective roles in mediating microglial Aβ clearance and turnover, while concurrently transducing potentially neurotoxic Aβ-induced inflammatory signals. To further define a role for TREM2 in Aβ clearance and Aβ-mediated microglial activation/cytokine expression, we plan to exploit use of TREM2 R47H knock-in and TREM2 WT and R47H overexpression mouse models currently housed in our laboratory to determine whether impaired TREM2/Aβ interactions can impair microglial response in the presence of Aβ. We will also characterize the role of the obligate TREM2 adaptor DAP12 in Aβ uptake/clearance and Aβ-mediated microglial activation/cytokine induction. These results will provide mechanistic insight into how TREM2/Aβ interaction can affect microglia-dependent Aβ uptake and turnover, and Aβ-induced microglial activation and inflammation. Given that ApoE is known to bind Aβ as well as TREM2, we will also determine whether microglial Aβ response above differs from response derived from Aβ/ApoE complexes. This provides essential groundwork in future strategies to optimize neuroprotective TREM2 Aβ clearance while limiting Aβ-induced microglial inflammation.

Public health relevance
PROJECT NARRATIVE TREM2 is a genetic risk factor for Alzheimer’s Disease (“AD”) expressed in microglia, where R47H variants demonstrate significantly increased risk in triggering AD onset. Although a mechanism for TREM2- dependent AD onset has not been well established, our results present a model where TREM2 R47H mutations compromise TREM2/Aβ binding interactions, which may impair TREM2-mediated Aβ clearance, and downstream microglial inflammatory cytokine release. Using TREM2 R47H knock-in and TREM2 WT/R47H overexpression mouse models, this study will define a role for Aβ/TREM2 interactions in microglia-dependent AD pathogenesis.